The role of the astrocyte immunoproteasome during chronic CNS autoimmunity

PROJECT SUMMARY/ABSTRACT
The purpose of this project is to identify a novel pathway of neuroprotection in the chronic progressive
phases of the immune-mediated disease multiple sclerosis (MS). Chronic progressive MS is largely
neurodegenerative as opposed to inflammatory; thus, it is not surprising that approved treatments, all of which
are immunomodulatory, have limited efficacy in treating progressive MS patients. Therefore, a paramount
necessity in MS research is to understand the mechanisms underlying progression in order to identify novel
therapeutic targets for the treatment of progressive MS.
Our previous studies revealed that immune cytokines act on regionally heterogenous astrocytes to yield
beneficial effects during protection and repair of the adult central nervous system (CNS) following injury. Since
astrocytes are abundant in MS lesions and have a critical regulatory role in CNS function and homeostasis during
inflammation, we hypothesized that astrocytes act as a pivotal regulator of immune-mediated processes during
chronic neuroinflammation. Towards this hypothesis, we identified a novel, interferon (IFN)γ-regulated pathway
active in chronic white-matter lesion astrocytes within progressive, postmortem MS patient tissue. We went on
to discover that IFNγ preferentially mediates upregulation of the immunoproteasome (iP) in primary astrocytes,
which leads to a reduction in damaging oxidative stress and protection from exacerbated chronic disease in an
in vivo murine model of MS, experimental autoimmune encephalomyelitis (EAE). Guided by strong preliminary
data, we propose to pursue three Specific Aims to elucidate how IFNγ mediates CNS protection via the astrocyte
iP during chronic neuroinflammation:
1) Determine the expression kinetics of the IFNγ-iP axis in astrocytes during MS and EAE.
2) Identify the mechanisms responsible for IFNγ-mediated survival and reactive oxygen species (ROS)
clearance in astrocytes.
3) Examine the role of astrocytic iP in modulating neurodegeneration.
Collectively, our proposed research strategy will broadly impact the field by dissecting previously
unknown kinetics and mechanisms underlying an undescribed pathway that is active in astrocytes during
neuroinflammation and it will reveal a paradigm-shifting protective role for immune cytokines and the iP during
chronic MS. Long-term, these studies may reveal novel therapeutic strategies for progressive MS patients and
have the potential to be extrapolated to other neurodegenerative diseases with known iP dysfunction.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis is an inflammatory demyelinating and neurodegenerative disease of the central nervous system. While current anti-inflammatory therapies are effective during the initial phase of the disease, they have limited success as the disease progresses, and in some cases even increase disease severity. Our proposed studies aim to understand how cells of the nervous and immune systems communicate to promote neuroprotection and reveal novel therapeutic targets that prevent neurodegeneration and disease progression during chronic phases of MS.